Molecular regulation of the AP2 clathrin adaptor complex

Abstract Clathrin-­mediated endocytosis is the main port of entry into our cells for medically relevant
substances including cholesterol-­laden particles and viruses such as influenza and hepatitis. By engulfing
signaling receptors, this fundamental cellular process also tunes our sensitivity to the potentially pathological
actions of growth factors and neuromodulators. As such, understanding how the underlying endocytic
machinery is regulated promises to reveal novel mechanisms that could be harnessed to control neoplastic,
neurodegenerative, cardiovascular, and viral diseases. At the heart of the endocytic process lies the AP2
clathrin adaptor complex which appears to undergo a conformational change during vesicle formation to
actively couple membrane and cargo to the clathrin coat. Despite the central role of AP2, we lack critical
details about how this molecular machine is regulated in vivo and how this regulation influences multicellular
systems. To address this need, we have developed innovative tools in C. elegans that allow us to quantify
AP2 activity at multiple levels and have employed deep genetic screens to identify three conserved protein
families that appear to govern AP2 conformation and activity. Our goal is to illuminate how these allosteric
regulators of the endocytic machinery function mechanistically. In Aim 1 we will validate our hypothesis that
adaptiN-­Ear-­Binding Coat-­Associated Proteins (NECAP)s counteract the active (open) conformation of AP2
to ensure proper recycling of adaptor complexes. We have discovered that AP2 accumulates in an active
state in NECAP mutants, and that NECAPs specifically bind open, phosphorylated forms of AP2. Using cryo-­
EM we have determined that the phosphorylated AP2 core bound to NECAP is conformationally inactive. We
will validate this structure in vivo and whether it reflects the end product of NECAP activity. Previously it was
thought that membrane phospholipids, cytosolic cargo domains, and phosphorylation by the AP2-­associated
kinase (AAK1) activate AP2. Our preliminary data indicate that a conserved region of the membrane-­
associated Fer/Cip4 Homology Domain-­only (FCHo) proteins is required to promote endocytosis by
converting AP2 to an active complex. We have named this functionally important domain the AP2 Activator,
or APA. In Aim 2 we will determine where the APA binds AP2 using cryo-­EM and test whether the APA is
sufficient to induce a structural rearrangement of AP2, as well as defining the roles of membrane, cargo, and
phosphorylation in that process. We will evaluate the physiological significance of AP2 phosphorylation by
characterizing kinase mutants. In our new Aim 3 we will examine how membrane trafficking influences tissue
physiology using our suite of assays to study a novel mutant in a tissue patterning inversin/nephronophthisis-­
2 protein called MLT-­4 that phenocopies loss of AP2 activity. The long-­term impact of the proposed research
will be to clarify how fundamental cellular machinery is controlled with spatiotemporal precision in metazoans,
where misregulation leads to important diseases.

Public health relevance
Project Narrative Our cells constantly engulf macromolecules, internalize ligand- bound receptors and recycle the plasma membrane itself, and the correct regulation of these processes is essential for the health of cells and the animals they form. Using unbiased genetic screens in C. elegans we have identified conserved regulators of the core endocytic machinery and will employ a multipronged approach to characterize their mechanisms of action at the molecular, cellular, and organismal levels. Because we are studying fundamental cellular machinery, understanding how it is controlled with spatiotemporal precision may inform the rational design of better therapeutics to treat an array of diseases that are thought to have an underlying endocytic component such as cancer, influenza, hepatitis, cardiovascular, and Alzheimer’s.